Core grant for vision research

The Center for Visual Science at the University of Rochester seeks to renew its NEI P30
Core Grant to support 23 participating investigators engaged in vision research. 13 of
the participating investigators hold a total of 17 eligible NEI R01 grants and these
investigators will have highest priority access to Core resources. An additional 21
affiliated investigators, who are engaged in vision research but are supported by other
sources, complete the Rochester vision community and will have access to Core
resources at reduced priority. Vision research at Rochester involves four major scientific
themes: Advanced optical technology for vision correction and retinal imaging, cell
biology of the normal and diseased eye, the neural mechanisms of vision, and vision in
behavior. Investigators represented by each of these themes will be served by four
Cores: An Administrative Core to ensure the equitable, fiscally responsible, and
scientifically productive distribution of Core technical services, a Computing Core that
provides applications programming for hardware control, stimulus generation, data
analysis, and modeling, an Imaging Core that provides expertise for histology,
microscopy, and low- and high-resolution in vivo imaging in mouse, monkey, rabbit and
human, and an Instrumentation Core that provides expertise in mechanical and
electrical engineering to develop novel instrumentation for vision research.

Public health relevance
The Center for Visual Science at the University of Rochester has a large and vibrant community of 41 scientists engaged in vision research. We seek to renew our NEI P30 Core funding that allows us to maintain a staff of 10 highly-skilled experts who are software, optical, mechanical, and electrical engineers, in addition to a histologist and a clinical imaging professional. These technical staff members meet the collective needs of CVS faculty in achieving their research goals of understanding normal vision, as well as diseases of the visual system and the therapies to treat them.